Brown Population Studies and Training Center

PROJECT SUMMARY
Population health statistics paint a sobering portrait of U.S. women’s health, particularly among
women from NIH-designated health disparity or understudied, underrepresented, and underreported
(U3) populations. The broad scope and unequal patterning of U.S. women’s health disadvantage
underscores the need for interdisciplinary research into related trends and trajectories, causes, and
consequences. In particular, as recognized in reports by the NIH and other scientific bodies,
population science on women’s health must consider a wide range of social and structural
determinants as well as the contributions of healthcare, medicine, and biology, requiring
interdisciplinary training and collaboration. To respond to this need, the Population Studies and
Training Center (PSTC) at Brown University requests supplemental funding to support the
development of research on women’s health among women from U3 populations under its Population
Dynamics Centers Research Infrastructure Program grant (P2CHD041020-23). This request is in
response to the Notice of Special Interest (NOSI): Research on the Health of Women of
Understudied, Underrepresented and Underreported (U3) Populations (NOT-OD-24-032). With this
supplement, PSTC will establish the Initiative in Women’s Health Equity to bring together scholars
from the social sciences, public health, and medicine at Brown with the overarching goal of building
interdisciplinary teams with diverse expertise to advance population science in this area. Expanding
the PSTC research portfolio to include research on women’s health that specifically focuses on
women from NIH-designated health disparity or understudied, underrepresented, and underreported
(U3) populations in biomedical research will enhance and expand science in PSTC’s Primary
Research Areas of Migration and Urbanization; Children, Families, and Health; Reproductive Health
and HIV/AIDS; Population, Development, and Environment; and Social Foundations of Health
Disparities. Applying PSTC expertise on the social and structural contexts that produce inequality,
and diminish health and well-being for marginalized populations, to research on women’s health, will
contribute to ORWH efforts to build interdisciplinary research focused on the effect of sex and gender
at the intersection of the social determinants of health and disease.

Public health relevance
PROJECT NARRATIVE Women have historically been understudied and underrepresented in health research with negative and uneven consequences for their health and wellbeing. This supplement will support infrastructure at the Brown Population Studies and Training Center to build interdisciplinary teams of scientists with diverse expertise to advance population research on the health of women of understudied, underrepresented, and underreported populations.